Advancing Sustainability of Evidence-Based Treatments in Community Mental Health

Project Summary/Abstract
Too many patients do not receive evidence-based treatments (EBTs) for mental health problems. In response,
implementation science has rapidly advanced to bring EBTs to routine practice settings, and thereby improve
patient outcomes. Unfortunately, research on sustainability of EBTs remains alarmingly limited. This is
concerning, given that EBT activities and benefits regularly decline post-implementation. To prevent these
declines, research on sustainability is urgently needed. Per NIMH’s Strategic Plan 4.2, this F32 will advance
research on sustainability – namely, sustainability (a) outcomes, (b) predictors, and (c) mechanisms – by
leveraging an ongoing, parent R01 (R01MH120147). The R01 focuses on implementation of an EBT in 10 of
California’s community mental health centers (CMHCs). Specifically, the CMHCs partnered with the R01 team
to implement the Transdiagnostic Intervention for Sleep and Circadian Dysfunction (TranS-C) for individuals
with serious mental illness. Additionally, the R01 was designed to test whether manipulating TranS-C to “fit” the
CMHC context would improve implementation outcomes by randomizing CMHCs to deliver Standard TranS-C
or Adapted TranS-C. Thus, the R01’s infrastructure allows this F32 to test three primary aims. Consistent with
Shediac-Rizkallah and Bone’s sustainability framework, Aim 1 will evaluate qualitative and quantitative
sustainability outcomes of TranS-C, with respect to continued (a) activities, (b) benefits, and (c) capacity. Aim 2
will use hierarchical linear modeling to evaluate whether manipulating treatment fit to context predicts
sustainability outcomes. Aim 3 will use structural equation modeling to test possible mediators – specifically,
provider perceptions of fit (i.e., acceptability, appropriateness, and feasibility) – of the relation between
manipulated treatment fit and sustainability outcomes. To accomplish these aims, the applicant will receive
training in: (1) sustainability of EBTs, (2) advanced quantitative analysis, (3) mechanistic research design, and
(4) qualitative and mixed methods approaches. The research and training opportunities offered by this
fellowship will be supported by the thriving research environment of University of California, Berkeley and
mentorship from the applicant’s Sponsor (Dr. Allison Harvey) and expert Consultants (Drs. Shannon Wiltsey
Stirman, Cara Lewis, and Sophia Rabe-Hesketh). Collectively, this F32 fellowship will support the applicant’s
career goals of becoming an independent investigator in implementation science with a program of research
that evaluates the predictors, mechanisms, and outcomes of implementation and sustainability of EBTs in
community settings.

Public health relevance
Project Narrative Although research on implementation of evidence-based treatments (EBTs) in community settings has advanced rapidly, research on sustainability of those EBTs is alarming limited. Using mixed methods, hierarchical linear modeling, and structural equation modeling, this study will evaluate predictors, mechanisms, and outcomes of sustainability of an EBT delivered to patients with serious mental illness and sleep and circadian dysfunction in 10 community mental health centers. In line with the NIMH’s Strategic Plan 4.2, the knowledge gained from this F32 will advance the field’s limited research on sustainability of EBTs in community settings, thereby improving the long-term effectiveness of existing mental health services.